Calpain-1 Activity and Central Arterial Aging

Angiotensin II (Ang II) signaling, including matrix metalloproteinase type II (MMP2) activation, has been linked to an age-associated increase in the migratory capacity of vascular smooth muscle cells (VSMCs), and other proinflammatory features of arterial aging. Calpain-1 activation is required for MMP2 expression in fibroblasts and is induced in cardiomyocytes by Ang II. The consequences of engagement of calpain-1 with its substrates in governing the age-associated proinflammatory status within the arterial wall are documented in this study. The present findings demonstrate that transcription, translation, and activity of calpain-1 are significantly up-regulated in rat aortae or early-passage aortic VSMCs from old (30-mo) FXBN rats compared to young (8-mo). Dual immunolabeling of the arterial wall indicates that colocalization of calpain-1 and Ang II increases within the aged arterial wall. To further explore the relationship of calpain-1 to Ang II, we chronically infused Ang II into young rats, and treated cultured aortic rings or VSMCs with Ang II. Ang II induces calpain-1 expression in the aortic walls in vivo and ex vivo and in VSMCs in vitro. The Ang II mediated, age-associated increased MMP2 activity and migration in VSMCs are both blocked by calpain inhibitor 1, calpastatin. Over-expression of calpain-1 in young VSMCs results in the cleavage of intact vimentin, and an increased migratory capacity, mimicking that of old VSMC, these effects are blocked by the MMP inhibitor, GM6001. Furthermore, age-associated central arterial wall stiffness is linked to extracellular matrix (ECM) remodeling, including fibrosis and vascular calcification. Ang II induces both MMP2 and calpain-1 expression and activity in the arterial wall. But the role of calpain-1 in MMP2 activation and ECM remodeling remains unknown. Thus, we investigated further. Dual histo-immunolabeling demonstrates co-localization of calpain-1 and MMP2 within old rat VSMCs and arterial walls. Over-expression of calpain-1 induces MMP2 transcripts, protein levels and activity, in part, by increasing the ratio of membrane-type 1 MMP (MT1-MMP) to tissue inhibitor of metalloproteinases 2 (TIMP2). The effect of calpain-1 over-expression-induced MMP2 activation is linked to increased collagen I and III production and vascular calcification. In addition, over-expression of calpain-1 also induces transforming growth factor-beta1/ SMAD (Sma and Mad: Mothers against decapentaplegic) signaling, elastin degradation, alkaline phosphatase activation and total calcium content, but a reduction in the expression of calcification inhibitors, osteopontin and osteonectin, in cultured VSMCs, in vitro and in carotid artery rings, ex vivo, is seen. These effects are partially abolished by TIMP2. Interestingly, both calpain-1 and collagen II increase with aging within human aortic intima. In the aged human aortic wall, both calpain-1 and collagen II are highly expressed in arteriosclerotic plaque areas compared to grossly normal areas. Cross-talk of two proteases, calpain-1 and MMP2, leads to secretion of active MMP2, which modulates ECM remodeling via enhancing collagen production and facilitates vascular calcification. Our recent studies indicate that calpain-1 is markedly expressed in the shoulder, base, and cap of human atherosclerotic plaques. Calpain-1 protein is significantly increased in the human grossly normal aortic walls, particularly in the intima with aging. Interestingly, age-associated increases of the milk fat globule EGF-8 (MFG-E8) fragment, medin, markedly enhances calpain-1 protein expression. These results establish calpain-1 as a novel molecular candidate to facilitate age-associated ECM remodeling and its attendant risk for atherosclerosis. The detailed molecular and cellular mechanisms behind age-associated hypertension, atherosclerosis and atherosclerotic plaque instability, and Alzheimers disease are still under investigation.